UK ASCEND (Achieving Success in Community-Engaged research to elimiNate Disparities)

PROJECT SUMMARY– OVERALL
The University of Kentucky (UK) will establish Achieving Success in Community-Engaged research to elimiNate
Disparities (UK ASCEND), driven by one overarching objective--advancing health equity by promoting
community-engaged research (CER) success among ESIs from diverse backgrounds. We propose the
comprehensive ASCEND Scholars Program (ASP), a CER Training Program followed by a robust CER Pilot
Program, infused with bi-directional engagement with community stakeholders. Compelled to overcome the
extreme health disparities experienced by Kentucky’s rural (particularly Appalachian), Black, Hispanic, and
socioeconomically disadvantaged populations, the proposed Center of Excellence in Investigator Development and
Community Engagement is led by multiple principal investigators with complementary expertise and experience,
scaffolded by a well-resourced and committed university structure and leadership, and centered within longstanding
community partnerships. Housed in UK’s preeminent health equity research and training center, the Center for
Health Equity Transformation (CHET), UK ASCEND proposes the following aims: (1): Coordinate bold and
effective scientific leadership and governance, fiscal and regulatory management, communication and
dissemination strategies, and evaluation to assess key outcomes on CER training and success (Administrative
Core). (2): Cultivate community-engaged health equity research success among diverse early stage investigators
(ESIs) by immersing them into a productive research career advancement program, the ASCEND Scholars
Program, consisting of a three-component CER Training Program followed by an opportunity to deploy those skills
through a CER Pilot Program, within an environment of strong community partnerships and institutional strengths
(Investigator Development Core); (3): Catalyze and sustain long-standing bidirectional community stakeholder-ESI
research partnerships and translate findings into sustainable community and system-level changes that advance
health equity (Community Engagement and Dissemination Core). We will focus on three outcomes: ESI CER
career development, community engagement, and ESI research success. Informed by the NIMHD Research
Framework and the Institutional Model for Faculty Diversity Framework, UK ASCEND takes a comprehensive
orientation to mitigating health disparities by fostering authentic exchanges among community stakeholders,
researchers, providers, and policymakers. UK ASCEND has the motivation, vision, and capacity to contribute to
remediating the nation’s worst health disparities by providing comprehensive, rigorous, and inclusive CER training
essential for impactful scientific discovery.

Public health relevance
PROJECT NARRATIVE Driven to overcome the extreme health disparities experienced by Kentucky’s rural (particularly Appalachian), Black, Hispanic, and socioeconomically disadvantaged populations, the University of Kentucky (UK) proudly proposes UK ASCEND (Achieving Success in Community-Engaged research to elimiNate Disparities). UK ASCEND will cultivate health equity and community-engaged research (CER) success among early stage investigators (ESIs) from diverse backgrounds by implementing and evaluating the innovative ASCEND Scholars Program (ASP). Housed in the Center for Health Equity Transformation and leveraging UK’s rich and collaborative community partnerships and institutional strengths, the ASP’s strategically designed, comprehensive CER Training Program leads directly into a CER Pilot Program that will provide the skills development, bi-directional engagement with community stakeholders, and preliminary studies needed to foster research independence and advance health equity.